Rodent Genetic Engineering Lab

PROJECT SUMMARY/ABSTRACT
The Rodent Genetic Engineering Laboratory Shared Resource (RGEL) supports all Perlmutter Cancer
Center (PCC) members and their colleagues with expert, affordable, and cost- and time-effective services for
the creation of genetically modified mouse models (GEMMs). RGEL is essential to the four PCC Programs’
desire to create ever more complex, accurate genetic models of human cancer; during the funding period, 25
funded grants and 64 publications used RGEL data. RGEL is directed by Sang Yong Kim, PhD, Associate
Professor of Pathology, who has more than 30 years of experience in rodent and small animal genetic
engineering. He and his team of three highly trained scientists provide state-of-the-art and cutting-edge services
for the de novo creation and derivation of transgenic, knockout (KO), and knock-in (KI) mice, re-derivation of
mutant mice, gene targeting in mESC, and an extensive array of genotyping capabilities. RGEL is located in the
Science Building, occupying 1130 sq. ft of dedicated space with a barrier specific pathogen-free (SPF)
environment laboratory, animal housing, and a non-barrier laboratory. Its unique capabilities and high level of
expertise make RGEL an essential resource for multiple PCC members. To ensure ongoing alignment with PCC
investigator needs, RGEL obtains yearly surveys and meets regularly with and internal advisory board
comprising PCC members and other NYU faculty to discuss potential future opportunities and utilization of
resources. RGEL is continually innovating, evaluating, and developing emerging technologies to extend the
breadth of our scientific and technical expertise. The rapid incorporation of new technologies and internal
development of innovative procedures by RGEL staff ensure that the four PCC Research Programs have access
to cutting-edge expertise for rapidly introducing critical mutations into the mouse germline without the need to
rely on outside vendors, which are more expensive and have lengthy timelines. The Specific Aims of RGEL
are: 1) To provide PCC members with access to, and expertise in, cost-effective, cutting-edge genetic
engineering services for mouse model generation, ensuring state-of-the-art support for pre-clinical research, 2)
To provide PCC members with mouse models for preclinical validation of target genes for therapeutic and drug
screening in a timely fashion, and 3) To advance innovative and novel approaches for genome engineering in
mESC for PCC members.